NEURAL NETWORKS FOR SPEECH PERCEPTION IN NOISE

[unreadable] DESCRIPTION (provided by applicant): This research addresses the neural bases of speech perception in noisy environments. With its singular role in communication, speech is perhaps the most important everyday stimulus for human beings. Yet rarely does speech occur under pristine conditions; competing voices, reverberations, and other environmental sounds typically corrupt the signal. This poses a continual challenge for normal listeners and especially for those with hearing loss. Among the 30 million Americans with hearing loss, many suffer depression and social isolation because of their difficulty communicating. In the half-century since the original formulation of the "cocktail party effect", scientists have established three key perceptual/cognitive factors that improve speech intelligibility in a competing background: acoustic cues, audiovisual integration (voice + mouth movements), and linguistic context. However, little is known about how these mechanisms are implemented in the brain, particularly at the level of large-scale functional neural networks. The proposed research uses functional magnetic resonance imaging (fMRI) integrated with psychophysics to address the three factors that determine intelligibility. Innovative neural network analyses test how interactions among brain regions accommodate degraded speech and improve comprehension. Our specific AIMS are to identify the neural networks mediating speech perception in noise, when intelligibility depends on: 1) Acoustic Cues, 2) Audiovisual Integration, and 3) Linguistic Context. This research program comprises a multipronged and highly cohesive body of work that will help secure our understanding of speech perception to its neurobiological foundations. Relevance to public health: We study how our brains understand speech in a noisy background, such as at a restaurant, ballgame, or office. Research like this may someday help to design better hearing aids and similar devices. It may also result in more effective listening strategies, both for those with healthy hearing and especially for those with hearing loss. [unreadable] [unreadable] [unreadable]